Coordinating Center Core

Abstract for Coordinating Center Core (CCC) The UPCI-CMCR-CCC will provide three critical services to NIAID and the other components of the 5 – 7 CMCR Programs. The CCC will cooperatively develop a program for archiving and distributing data from 5 – 7 CMCR sites and will maintain electronic data storage and develop security passcodes and validations for retrieval of data. The CCC will develop a program for timely submission of data and data analysis at NIAID/NIH and maintain rapid availability of electronic exchange of records to CMCR Programs as well as the general scientific community. The CCC will coordinate administrative activities for the scientists organizing national meetings, coordinating conference calls, establishing three levels of firewalls to distribute information at levels of CMCR Centers locally, CMCR Programmatic Centers for all 5 – 7 programs, and to the general scientific community. Finally, the CCC will administer funds for the development of web-based training programs in four key areas: 1) Principles of Radiobiology, 2) Use of assays, methods, reagents, and animal models, 3) Technologies to study radiobiology and develop new product regulatory process, and, finally, 4) A course on triaging radiation casualties in the event of a radiation terrorist event.